Rio Grande Valley Cancer Health Disparity Research Center

Cervical cancer (CxCa) stands as a significant cause of cancer-related deaths among women globally.
Specifically, in the Rio Grande Valley (RGV), comprising Cameron, Hidalgo, Willacy, and Starr counties, the
highest CxCa mortality in the U.S. has been identified. The initiation of HPV infection represents a pivotal event
in the malignant transformation of the cervical zone, established as the primary cause leading from intraepithelial
lesions to CxCa. The most prevalent cytopathologic manifestations of cervical HPV infection are low-grade
squamous intraepithelial lesions situated in the cervix's transformation zone. The prevalence of HPV infection
and its various genotypes differs significantly worldwide. Different populations may harbor distinct HPV
genotypes within their genital tracts. Nevertheless, factors such as high poverty rates, poor nutrition, unknown
environmental influences, socio-behavioral elements, and limited education along the Mexican border might also
significantly contribute to this health disparity. Understanding the disease pathology and devising new
approaches to combat it in specific populations necessitates crucial information regarding HPV prevalence, HPV
genotypes, and the frequency of HPV 16 E6 genomic variance among women from diverse populations, along
with their associations with socio-behavioral factors. However, this vital information, concerning either HPV
prevalence or the distribution of HPV types, remains unavailable for RGV women, who are profoundly affected
by CxCa. Consequently, we propose investigations to gather this critical information regarding RGV women. We
believe this knowledge will be immensely valuable in mitigating the CxCa disparity among this highly
underserved population. Our hypothesis posits that analyzing HPV genotype prevalence, frequency of HPV
16 E6 genomic variants, and immunological factors will illuminate the cause of CxCa disparity in RGV
women. In aim 1, we will determine the prevalence of HPV infection and identify the specific HPV types of
present. This analysis will involve cervical mucosa samples collected from women in rural RGV. Samples from
Caucasian women will also be analyzed for comparison. In aim 2, we propose investigating the existence of Ig
types (representing the humoral response), cytokines (representing the cellular response), and genetic
polymorphisms within immune response genes in cervical mucosa samples. Aim 3, achieved using PDX mouse
models of HPV16 E6 variants, is designed to explore the frequency and incidence of different HPV16 E6 genomic
variants, investigating their oncogenic, metastatic potential, and role in drug resistance, all contributing to the
aggressiveness of the disease and poor therapeutic outcomes of CxCa. The outcomes of this study will be
instrumental in developing innovative prevention and therapeutic strategies to alleviate the CxCa disparity among
the RGV Hispanic women population.